Dupilumab in the Treatment of Pediatric Alopecia Areata

PROJECT SUMMARY/ABSTRACT
Alopecia areata (AA) is a T cell–mediated, hair-specific disorder with a 2.1% lifetime risk, that recently has been
also associated with Type 2 polarization and atopic comorbidities. 14%-25% of AA patients progress to alopecia
totalis (AT) or even whole-body hair loss [alopecia universalis (AU)]. A large unmet need exists for efficacious
and safer therapeutics for extensive AA patients (≥50% scalp loss), such as targeted therapeutic strategies that
are now in use for other immune-mediated skin diseases such as atopic dermatitis (AD). This is particularly
important in children, where treatments suitable for long-term use are not available. In a well-characterized
clinical trial with 60 adult AA patients, we have recently showed that dupilumab, a monoclonal antibody that
inhibits IL-4/IL-13 signaling by blocking the IL-4Rα subunit, induced significant hair regrowth, and significantly
modulated the molecular AA phenotype in scalp tissues, particularly in patients with high IgE and/or atopic
comorbidities, opening the door for targeted treatments for younger subjects with extensive AA. These data
established a solid rationale for the potential of dupilumab to induce hair regrowth in pediatric AA patients with
an atopic background. We hypothesize that the Th2 cytokines IL-4 and IL-13 are “drivers” in AA and their
inhibition with dupilumab in pediatric AA subjects with an atopic background and/or high levels of IgE
will shed light on the role of Type 2 inflammation in AA and the immune and regulatory pathways
underlying suppression and/or induction of hair-associated keratins. We will test our hypothesis in a
double-blinded clinical trial in 76 children (6-17 years old) with extensive AA (>/=50% scalp), randomized 2:1 to
dupilumab or placebo, respectively, for 48 weeks, followed by another 48 weeks of open label dupilumab, and
16 weeks of follow-up (for a total of 112 weeks). We will test our hypothesis with the following specific aims
(Aim 1 is related to clinical effects, while Aims 2 and 3 are translational aims): 1. To assess the safety,
tolerability clinical efficacy, and durability of response with subcutaneous administration of dupilumab
in pediatric subjects with severe (≥50% scalp) AA and high IgE and/or atopic background; 2. To evaluate
the ability of specific Th2 antagonism with dupilumab to modulate Th2 and other immune and regulatory
pathways, as well as hair keratins, and stem cell biomarkers in scalp of children and adolescents with
extensive AA; and 3. To characterize the ability of dupilumab to modulate inflammatory, regulatory, and
tolerogenic immune pathways in blood of pediatric AA patients during and after treatment. By closely
coupling biomarkers with clinical response, this trial will permit the maximal translational advantage. This study
will expand our mechanistic understanding of AA in children and if successful, it may change the treatment
paradigm for pediatric AA, enabling the use and further development of targeted therapeutics.

Public health relevance
PROJECT NARRATIVE Alopecia areata (AA) is a complex T-cell-driven disease, lacking treatments in children with moderate-to-severe AA. We have established a Type 2 immune polarization in AA, particularly in atopic patients, and also the ability to regrow hair with specific Th2-targeting with dupilumab in adult patients with atopy and/or high IgE. In this placebo-controlled study we test the safety and efficacy of dupilumab in children (6-17yo) with extensive (≥50% scalp loss), coupled with molecular profiling of inflammatory, regulatory, and hair-associated keratins, with the potential to change the treatment paradigm for children with AA, and also expand its mechanistic understanding.